Investigating Multiple PK and PD Relationships for TB-HIV (IMPPRove TB-HIV)

PROJECT SUMMARY
Tuberculosis (TB) is the leading infectious cause of mortality globally after COVID-19. TB and HIV interact
synergistically, each worsening the outcomes of the other. A key driver of unfavorable TB treatment
outcomes is suboptimal drug exposures. However, target drug concentrations of first-line TB drugs and
cumulative exposure thresholds needed for optimal clinical outcomes, post-TB lung health, and prevention of
emergence of resistance are not defined, particularly in programmatic settings. In our study entitled
“Investigating Multiple PK and PD Relationships for TB-HIV (IMPPRove TB-HIV)," we will leverage the
Tuberculosis Sentinel Research Network (TB SRN), a large global platform cohort study for coordinated
observational TB research conducted among persons with pulmonary TB with and without HIV, within the
International epidemiology Databases to Evaluate AIDS (IeDEA) consortium in six IeDEA regions, to conduct
pharmacokinetic-pharmacodynamic (PK-PD) analyses, using a nested case-cohort design. We will measure
individual PK via collection of dried blood spots (DBS), which are easy to collect, store, and ship, and
cumulative drug exposure in hair, which reflects both adherence and PK. In Aim 1 (PK-PD aim), we will
examine the impact of TB drug PK and cumulative drug exposure on risk of unfavorable TB treatment
outcomes (death, failure, recurrence) among individuals with pulmonary TB, with or without HIV. In Aim 2
(PK-resistance aim), we will investigate the impact of drug exposures on emergence of TB drug resistance
mutations. In Aim 3 (PK-lung health aim), we will evaluate the association between anti-TB drug exposures
and post-TB lung disease and longitudinal lung health. Thus, the IMPPRove study aims to elucidate the
relationships between drug exposures and unfavorable TB treatment outcomes, poor lung health, and
resistance under field conditions, in a large multinational patient population, taking into account HIV status
and other factors known to affect these outcomes. The goal is to inform optimization of TB treatment (right
dose, right patient) to improve clinically-important outcomes for patients.

Public health relevance
NARRATIVE Tuberculosis (TB) is a curable disease, yet many people respond poorly to treatment, which can lead to death, treatment failure, relapse, emergence of drug resistance, or lung damage with long-term respiratory complications. In this study, we will evaluate tuberculosis drug concentrations in dried blood spots and cumulative drug exposures in hair and study their relationship to treatment response, acquired drug resistance, and lung health in the context of a large cohort study called the Tuberculosis Sentinel Research Network (TB-SRN). The overall goal is to determine the right doses of first-line TB drugs to promote optimal TB treatment response and post-TB health, with a specific focus on people living with HIV.